Functional Genomics and Bioinformatics Core

PROJECT SUMMARY
The Functional Genomics and Bioinformatics Core facility in the Center for Pediatric Research offers efficient,
high quality and flexible services in molecular and genomics assays for COBRE Project Leads and other
researchers in Sanford Research and regional institutes. The establishment and operation of the Core provides
a centralized resource for infrastructure, expertise, equipment and technical capabilities to perform molecular
and functional genomics studies proposed by COBRE Project Leads. The Functional Genomics and
Bioinformatics Core facility provides personalized services for investigators from experimental design to assay
execution and data analysis. The state-of-the-art, high-throughput equipment in the laboratory enables a wide
range of molecular and genomics assays, including nucleic acid isolation and quality analysis and
manipulation, quantitative real-time PCR analysis, RNA in situ hybridization, chromatin immunoprecipitation
studies, bioinformatics services, and to facilitate CRISPR/Cas9 mediated genome editing and. In addition, the
Core facilitates high-throughput sequencing and bioinformatics studies. These services provided by the Core
have contributed extensively to publications, grant applications, and preclinical studies by Project Leads. A
plan is developed for a sustainable Core facility beyond COBRE funding period to meet the research demands
of our scientists. By providing the support, resources and expert Core services, the Functional Genomics and
Bioinformatics Core will enhance the overall institutional research capacity and promote the advancement of
this core group of scientists and physicians to build a stronger pediatric research program, and ultimately
increase the number of NIH-funded biomedical researchers in South Dakota.